Core 2: Analytical Core

ABSTRACT – ANALYTICAL CORE
The Analytical Core will serve as a central resource for the deep systems-level molecular characterization of
biological samples generated by the Projects and from the Biospecimens Core. The primary objective of this
Core is to integrate diverse single cell, bulk, and spatial analytical platforms to define the complex interactions
between brain tumor cells and the associated brain tumor microenvironment (TME). To this end, we have
developed an analytical platform encompassing transcriptional profiling at the single cell, single nuclei, and bulk
tissue scale; protein expression profiling, phosphoproteomics and immunopeptidomics with cell type-specific
resolution; and quantitative metabolomics and drug distribution profiling with high spatial resolution by mass
spectrometry imaging (MSI). These complementary analytical approaches have the requisite sensitivity to
generate ultra-deep systems-level molecular profiling of 10-20 micron thick tissues from single core biopsies;
performance of our platform has already been demonstrated on multiple image-guided core biopsies from
geographically distinct regions of a GBM tumor. Multi-omics data acquired in our Analytical Core will be managed
using a FAIR compliant metadata management tool that prioritizes connections between samples and defines
discrete sample types that can be freely connected as described in the Overall Section of our proposal. The
Analytical Core will provide expert personnel, facilitate the sharing of knowledge within the program, and maintain
the sophisticated equipment necessary to generate data for both Projects. By acting as a common resource, the
Analytical Core provides expertise for each Project.